Development of an Integrated mHealth App-Based Intervention to Support Smoking Cessation in People Living with HIV

PROJECT SUMMARY / ABSTRACT
The advent of highly active antiretroviral therapy (HAART) has greatly reduced mortality in persons living with
HIV (PLWH), to the point where now lifestyle-related factors pose greater threat to long-term survival than HIV,
chief among them smoking. Although interest in quitting smoking is high amongst PLWH, the prevalence of
smoking among PLWH remains more than twice as high as that in the general population. Encouragingly,
there have been successes in leveraging HIV primary care settings to engage PLWH smokers in smoking
cessation efforts. Scaling up and expanding on this success has been difficult, however, as past evidence has
indicated that interventions with more sessions produced stronger effects. High intensity face-to-face
interventions are not readily scalable. Mobile health (mHealth) approaches, however, can provide continuous
and as-needed support over longer periods of time, reducing the need for in-person treatment while providing
prolonged support. To this end, and building on our previous work, we propose to develop an mHealth
intervention that integrates (1) the “Smiling instead of Smoking” (SiS) app, a conceptually-grounded,
iteratively developed smoking cessation smartphone app (M-PI Hoeppner), (2) a successful face-to-
face smoking cessation treatment for SLH, called QUIT (M-PI O'Cleirigh), and (3) Life Steps, our
efficacious brief intervention to promote adaptive engagement in HIV care. This integrated treatment will
be informed and specified through the completion of the treatment development aims. We anticipate that it will
combine initial face-to-face, SLH-focused treatment with SLH-adapted, real-time, temporally tailored
smartphone app support over 8 weeks. Aim 1 is to build the integrated mHealth app intervention (SiS-H)
based on feedback derived in user-centered design research with smokers living with HIV (SLH), consultation
with HIV smoking cessation scientists and clinicians, and collaboration with our software development partner.
Aim 2 is to conduct a proof-of-concept randomized controlled trial to test the feasibility, acceptability, and
preliminary efficacy of SiS-H, while tracking HIV-specific outcomes. The app to be adapted is Version 3 of the
SiS app, which is based on social cognitive theory, and implements clinical practice guidelines within a positive
psychology framework. The proposed integrated treatment will emphasize protecting the experience of
positive emotions among SLH as they navigate quitting smoking, and support increased self-efficacy through
the complementing skills-based training of the QUIT and Life Steps components. The proposed project
advances the critically important public health goal of making smoking cessation support more readily available
to PLWH smokers. More pragmatically, data from this project could inform the design of a larger R01-funded
RCT and the necessary regulatory strategy to advance towards approval of SiS-H as a prescription treatment
that could well be sustainable in HIV primary care and other community health clinical settings.

Public health relevance
PROJECT NARRATIVE HIV positive smokers lose more life-years to smoking than to HIV. Public health efforts to reduce the prevalence of smoking have under-served this important population, as demonstrated by the prevalence of smoking among persons living with HIV, which is more than twice as high compared to the general population. We propose to develop an integrated smoking cessation treatment that builds on our expertise and the field's successes in leveraging the HIV clinical care setting and smartphone app technology to provide scalable, tailored, sustained smoking cessation support to HIV positive smokers.